Accelerated Flap Coverage Versus Standard Timing in the Treatment of Severe Lower Extremity Musculoskeletal Injuries

In the United States (US), there are more than 300,000 lower extremity musculoskeletal injuries each year. In
patients with severe injuries, 20-40% will develop an infection. Patients at highest risk for infection have open
injuries where the bone breaks through the skin causing skin and muscle damage that require soft tissue
reconstruction with a flap. A flap is vascularized tissue that is moved from one area of the patient's body to the
injury site to reconstruct the damaged soft tissues. Prior studies have optimized many aspects of lower extremity
trauma care for severe injuries. Despite extensive prior work, the timing of the flap surgery has not been
rigorously evaluated. In the US, the mean time from injury to flap surgery is 10 days and infection rates are 20-
40%. There is evidence to suggest that an alternative approach of early flap coverage might reduce the risk of
infection. Studies have shown that when the time between injury and the flap surgery was 72 hours or less,
infection rates were reduced. Mechanistically, this makes sense. Faster soft tissue reconstruction of the open
wound requires early high-quality debridement at specialized centers and leads to early antibiotic delivery and
the prevention of nosocomial contamination. The existing data and this rationale led the United Kingdom (UK) to
develop guidelines for early flap coverage. Following guideline implementation, infection rates dropped to less
than 10%. Despite this success, practice outside of the UK has not changed. We believe this is due to inadequate
evidence to motivate surgeons and hospitals to mobilize the resources required to change the time to flap from
10 days to less than 72 hours. Resources required include timely transport of patients to specialized centers and
a re-prioritization of operating room and surgeon availability. In existing studies, the time from injury to flap is
highly influenced by several confounding factors, namely, injury severity and practice environment which are not
adequately controlled for in non-randomized studies. While the existing retrospective and non-comparative data
are promising, given the resources required to change, higher quality evidence is needed. The proposed trial will
address this knowledge gap. This is an international randomized controlled trial of 356 patients with severe
fractures and/or dislocations below the knee that require flap surgery for initial injury management. Patients will
be randomized 1:1 to accelerated flap surgery within 72 hours of injury versus standard of care flap surgery
timing. The trial's overarching objective is to determine if accelerated flap timing reduces infection. The primary
outcome is a 6-month composite clinical status outcome, hierarchically assessed as: 1) mortality, 2) amputation,
3) re-operation, and 4) days in the hospital. This trial will test three specific aims: 1) to determine if accelerated
flap surgery leads to improved clinical status at 6 months, 2) to determine if accelerated flap surgery leads to
improved clinical status at 12 months, leads to improvements in the individual components of the composite
outcome at 6- and 12-months, and 3) to determine if accelerated flap surgery improves quality of life over 6
months and over 12 months.

Public health relevance
PROJECT NARRATIVE The proposed trial is a 356-patient international randomized controlled trial (RCT) comparing accelerated flap surgery (within 72 hours of injury) to standard of care flap timing (approximately 5 to 15 days) in patients with severe lower extremity injuries that require a flap for initial injury management. We hypothesize that accelerated flap surgery (within 72 hours of injury) compared to standard of care flap timing will improve patient-important outcomes as measured with a 6-month composite clinical status outcome hierarchically assessed as mortality, amputation, re-operation for infection or flap compromise, and days in the hospital. If successful, this trial will provide the rigorous, high-quality evidence needed to lead to a global paradigm shift in post-injury flap timing, a substantial reduction in infection and infection-related complications, and a corresponding improvement in patient-centered outcomes.